CORE--STATISTICS

The Statistical Core will be responsible for all statistical and data management aspects of the Program Project. Consultation on experimental design and statistical analysis has been and will continue to be available to all participating investigators. The Statistical Core will integrate the Program Project data with information that is available in the Rush Alzheimer's Disease Registry and maintain a comprehensive data base of all Program Project data. Statistical Core personnel will also provide statistical analyses for all components of the Program Project. Data entry for investigators needing such service will also be provided.